Symposium to Advance Total Worker Health

PROJECT SUMMARY
Our primary objectives for the Total Worker Health® education planning workshop (workshop) and the 4th
International Symposium to Advance Total Worker Health® (Symposium) are to convene stakeholders
across academia, industry, labor, and government to explore research and case studies in TWH, to establish
partnerships and collaborations that advance TWH, and to build capacity by providing the necessary knowledge
and skills to professionals, employers, workers, educators, policymakers, and students. The Workshop aims to
convene a diverse group of participants to set the agenda for the 2025 Symposium as well as broader action
steps for TWH educational offerings. The three-and-a-half-day hybrid Symposium will include a mix of sessions
and preparatory workshops emphasizing the latest TWH science and practice. Our goal is to support prior and
current NIOSH TWH initiatives, as well as national and global demands to protect and enhance the health of all
workers. We have three main goals:
1. Identify and share the most compelling research, education, and interventions that advance worker
safety, health, and well-being,
2. Build collaborations between different stakeholders (e.g., researchers, educators, employers,
government agencies, business professionals, public health professionals, and others), and
3. Disseminate findings to advance TWH research, education and practice that address existing and
emerging issues facing workplaces and workers globally.
The overall aim of the Symposium is to enhance both the work environment as well as prevention efforts that
advance worker well-being through research, education, and practice. These events will significantly contribute
to advancing national goals set by NIOSH to reduce injuries and illnesses through enhancing training and
professional development in TWH. It will do this by better understanding workplace interventions, research
methodologies, and applied TWH practices. The planning committee will address diversity and inclusion as
priority areas for submissions, keynote speakers, and the overall program. We will include strong research to
practice (r2p) emphasis, as well as the advancement of a TWH research agenda, that aligns with the NIOSH
National Occupational Research Agenda (NORA) goals, in particular those cross-sector goals relevant to the
NIOSH FY2019-2026 strategic plan.
Short term outcomes will include general satisfaction with the Symposium, including the quality and relevance
of sessions and perceived changes in knowledge and abilities as a result of attendance. Intermediate outcomes
will include increased engagement and new collaborations that develop because of attending the conference.
The key long-term outcome is to increase the capacity and collaboration of researchers and practitioners focused
on TWH studies and interventions to improve the effectiveness and sustainability of TWH implementation.

Public health relevance
PROJECT NARRATIVE The 4th International Symposium to Advance Total Worker Health® will have a high public heath impact by meeting the national and international needs for increasing research and practice in Total Worker Health (TWH). We will meet this objective by hosting a TWH education planning workshop in the first project year to identify gaps and opportunities for TWH training and to inform the themes of the Symposium. Our primary objectives are to convene stakeholders across academia, industry, labor, and government to explore research and case studies in TWH, to establish partnerships and collaborations that advance TWH, and to build capacity by providing the necessary knowledge and skills to professionals, employers, workers, policymakers, community groups, and students.